Pregnancy complications, future cardiovascular disease risk factors and cardiovas

DESCRIPTION (provided by applicant): Currently available cardiovascular (CVD) risk scores in women usually include risk factors which are gender- neutral and often lead to underestimate of CVD risk. There are factors in the life course of women that are unique and gender-specific which relate to long-term CVD risk. Pregnancy is considered a cardiometabolic stress test such that adverse pregnancy factors/outcomes in a woman, predict future CVD risk factors and incident CVD. The American Heart Association and American College of Cardiology Effectiveness-Based Guidelines for CVD Prevention in Women recommend taking a pregnancy history for CVD risk stratification, however it is unclear which pregnancy factors are independently related to CVD when taken together. Specific pregnancy factors that have been demonstrated to predict CVD risk factors and CVD include pregnancy- induced hypertension or pre-eclampsia, gestational diabetes, having a small for gestational age infant, a low or very high number of pregnancies, pre-term delivery, stillbirth and a history of subfertility. We believe thata pregnancy risk score derived from these candidate pregnancy factors will help medical caregivers determine which specific factors in a woman's pregnancy history are most important as far as predicting future CVD risk factors and future CVD. A pregnancy risk score may help providers with personalized, earlier referral for upstream risk factor modification and may also allow a woman to assess her own CVD risk. In this proposal, we have the following three research goals: 1. To determine which subset of pregnancy related factors is related to blood pressure, oral glucose tolerance test and lipid profile, in the Västerbotten Intervention Programme (VIP) when linked to the Swedish Population Registers (estimated n=16,041). 2. Utilize a multiple- marker approach to develop and validate a pregnancy factor risk index in the Swedish Population Registers (estimated n=800,000) and 3. To determine whether the pregnancy factor risk score (developed in specific AIM 2) improves CVD risk stratification (discrimination, calibration and net reclassification) above and beyond established CVD risk factors among women using the VIP dataset linked to Swedish Population Register.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cardiovascular disease is a leading cause of death in women. Pregnancy related factors including number of pregnancies, having small infants, preterm delivery, stillbirths, gestational diabetes and pregnancy-related hypertension are an early window into later life cardiovascular disease in women. We aim to better understand how pregnancy factors lead to hypertension, diabetes and abnormal cholesterol levels and to develop a pregnancy factor clinical risk score to help us easily identify women who are at risk for developing later-life cardiovascular disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Heart disease and stroke are the number one and three leading causes of mortality in U.S. women, respectively.(1) The importance of knowing whether a woman is at low, medium or high risk for cardiovascular disease over her lifetime is important when considering when and how aggressively to modify her CVD disease risk factors. If we had an earlier window into a woman's level of CVD risk, we may be better able to institute both early risk factor modification as well as primordial prevention- or prevention of the risk factors themselves.(2) Pregnancy represents an ideal early window given that a majority of women have a pregnancy in their lifetime (e 80%) and since pregnancy is considered a "cardiometabolic stress test",(3) such that adverse pregnancy outcomes predict both CVD risk factors(4) and incident CVD.(5) Candidate pregnancy factors that are related to CVD far beyond the childbearing years and that should be considered when creating a pregnancy risk score for CVD include 1. pregnancy- induced hypertension/ pre-/eclampsia, 2. gestational diabetes mellitus (GDM), 3. delivering a small for gestational age (SGA) infant, 4. number of pregnancies, 5. preterm delivery, 6. stillbirth and 7. history of subfertility (inability to conceive after e 1 year of attempt). Recent American Heart Association and American College of Cardiology (AHA/ACC) effectiveness-based guidelines recommend taking a pregnancy history as a means to further risk stratifying women.(6) However, it is uncertain whether these pregnancy factors are solely antecedents of well-established CVD risk factors such as hypertension, diabetes and dyslipidemia, or whether they act via novel mechanisms to independently or synergistically predict cardiovascular disease. It is also unclear which of these pregnancy factors most strongly and independently are related to CVD when considered together. We believe our proposed study will help to close this important scientific gap and will better inform recent AHA/ACC recommendations to take a pregnancy history when risk stratifying women for CVD. AIM 1: Determine which subset of pregnancy related factors best predicts each of the three sets of established cardiovascular disease risk factors. Study Sample for AIM 1: (Vasterbotten Intervention Program or VIP) when linked to the Swedish Medical Birth and Population Registers (estimated n=16,041): Hypothesis 1: There is a parsimonious set of pregnancy factors that can predict: a) Blood pressure (systolic and diastolic) b) Oral glucose tolerance test value c) Dyslipidemia (LDL, HDL and triglycerides). AIM 2: Utilize a multiple-marker approach to develop and validate a pregnancy factor score for CVD. Study Sample for AIM 2: Swedish Medical Birth and Population Registers (estimated n=800,000) Hypothesis 2: A pregnancy factor risk index can predict CVD in women. AIM 3: Determine whether the pregnancy factor risk score (developed in specific AIM 2) improves CVD risk stratification above and beyond established CVD risk factors among women Study Sample AIM 3: (Vasterbotten Intervention Program or VIP) when linked to the Swedish Medical Birth and Population Registers (estimated n=16,041): Hypothesis 3: The pregnancy risk score will improve the global fit of a CVD risk prediction model, model calibration, net-reclassification and model discrimination above and beyond established CVD risk factors.